Determining the Role of Distinct Parafascicular Thalamic Circuits in Motor Behaviors Relevant to Parkinson’s Disease

Project Summary
The ability to move from one place to another and acquire different motor skills is critical for our survival. Many
human disorders including Parkinson's disease, Huntington's disease, and Tourette syndrome, cause
abnormal motor behaviors. Identifying neural circuits that mediate locomotion and motor learning are therefore
crucial both in terms of basic science and understanding how their dysfunction in disease models may
contribute to motor defects. Parafascicular (PF) thalamus has extensive connectivity within the basal ganglia
motor system, and is involved in reversal learning as well as the initiation of movement sequences. Although
heterogeneity within PF thalamic neurons has been reported at the cellular level, the functional relevance of
distinct PF subpopulations in motor behaviors remains unknown. The central hypothesis of this proposal is that
PF thalamus contains distinct projection-specific subpopulations that mediate different motor processes.
During the K99 phase, using chemogenetic neuronal inhibition and in vivo calcium imaging, I will test the
hypothesis that the thalamostriatal (PF!dorsal striatum) pathway is mainly involved in locomotion whereas the
thalamosubthalamic (PF!subthalamic nucleus) pathway is mainly involved in motor learning. By comparing
inputs from motor cortex, globus pallidus, and substantia nigra to these PF subpopulations followed by
optogenetic circuit manipulations, I will identify PF subpopulation-specific inputs that are critical for their
behavioral contributions. During the R00 phase, using ex vivo electrophysiology, I will determine how these two
PF circuits are altered in a mouse model of Parkinson's disease, which will set the stage for the identification of
circuit-based manipulations that may rescue both locomotion and motor learning in this mouse model. To
further these rescue experiments, I will perform single cell RNA sequencing of the two PF subpopulations in
wild type mice to identify potential molecular targets capable of rescuing both motor phenotypes in Parkinson's
disease mice. Together, the proposed project will not only enhance our understanding regarding the role of
distinct PF circuits in motor functions, but also potentially indicate that targeting PF circuits may be sufficient to
rescue multiple motor phenotypes in neurodegenerative disease models. The proposed research and career
development plan will be conducted in the lab of Dr. Guoping Feng at the Broad Institute of MIT and Harvard,
which will prepare Dr. Dheeraj Roy to direct an innovative research program as an independent investigator
studying neural circuit mechanisms mediating normal and disease states.

Public health relevance
Project Narrative Motor impairments are among the most debilitating symptoms in a wide range of neurodegenerative disorders, including Parkinson's disease. This project will determine the role of distinct subpopulations of neurons in parafascicular (PF) thalamus in regulating locomotion and motor learning processes, which are commonly disrupted in movement disorders. By characterizing the dysfunction of PF subpopulations in a mouse model of Parkinson's disease, this project will identify PF circuit manipulations capable of treating multiple motor phenotypes.